CARDIOVASCULAR OUTCOMES RESEARCH TRAINING PROGRAM

Project Summary/Abstract
As the leading cause of death and disability in the United States, cardiovascular disease has benefitted
from immense research investments to improve the care of afflicted patients. However, the application of this
knowledge in routine clinical practice has been variable and the evaluation of more patient-centered outcomes,
including patients’ symptoms, function and quality of life, are desperately needed. Not only do these knowledge
gaps limit the potential for US healthcare to improve, but evolving changes in reimbursement from a volume- to
value-based payment models have created an unparalleled demand for cardiovascular outcomes researchers.
This renewal application seeks to continue a highly successful program for training post-doctoral scholars to
independently perform clinically-oriented outcomes research. It extends and improves the University of Missouri-
Kansas City (UMKC)’s outcomes research training program, which is unique in the Midwest and serves as a
central unifying research program for our region. The 2-year training program has 3 synergistic components: 1)
a basic foundation of in clinical research (including a Masters degree in bioinformatics with a clinical research
emphasis), 2) specialized skills for outcomes research coupled with academic ‘survival skills’ (our outcomes-
based core curriculum), and 3) hands-on research. Hallmarks of the research experiences include multi-
disciplinary group mentorship, individualized mentorship to meet each trainee’s needs; access to numerous
existing data, as well as clinical populations for primary data collection and implementation; training in
entrepreneurship; and highly experienced statistical support. Enhancements planned for the existing program
include 1) a more robust collaboration with the University of Missouri system, which is investing in the NextGen
Precision Medicine institute and for which our program serves as the central pillar for precision healthcare
delivery; 2) increased engagement in clinical trial design and execution; and 3) access to a new community
collaboration of 19 regional hospitals innovating healthcare delivery to improve its value (www.kcqvic.org) for
deeper exposure to implementation research. Administering the program will be an experienced program
director, supported by well-qualified associate and assistant directors and mentors with expertise in economics
and decision analysis; large database analysis; bioinformatics; qualitative and implementation research; study
design, methodology and statistics; patient and clinician behavior change; community-based participatory
research; entrepreneurship; shared medical decision-making and patient-centered research; multi-disciplinary
cardiovascular research; disparities research; and risk models and creation of clinical tools, as well as an
advisory committee of national leaders. Collectively, our committed team will provide a formal training,
mentorship and evaluation program to continue and enhance our prior success in supporting the ability of
trainees to make significant contributions to the scientific literature and to embark on successful academic
research careers.

Public health relevance
Project Narrative While it has been over 20 years since the Institute of Medicine called for more evidence-based, patient- centered care, cardiovascular care is still highly variable and fails to achieve its full potential. The UMKC T32 in Cardiovascular Outcomes Research trains diverse, talented post-doctoral scholars committed to improving the quality and value of healthcare though knowledge generation, implementation and evaluation of healthcare innovations.